ERIS - Effective Reserve In Stroke

PROJECT SUMMARY/ABSTRACT
Stroke and dementia are two of the leading contributors to age-related disease burden and long-term disability.
With aging populations in the US and worldwide, the prevalence of stroke increases and it becomes imperative
to prevent related long-term functional disability from cerebrovascular disease and pathology. Understanding the
determinants of post-stroke outcome that may lead to functional independence is of great clinical significance
and essential to developing targeted treatment options. In the field of neurodegenerative diseases, the concepts
of structural and functional reserve have been invoked to explain better than expected cognitive outcomes.
Reserve describes the brain’s capacity to compensate for pathology. Specifically in stroke, elucidating such
protective mechanisms has major practical implications for understanding outcome, however, few studies have
investigated these concepts in stroke populations. Structural reserve generally aims to quantify the maximum
brain reserve of a person, while pre-existing disease burden is not accounted for. The remaining, effective
reserve, however, more likely reflects the brain’s ability to compensate for a sudden vascular event. The overall
goal of this project is to create a translational approach to estimate the effective reserve from the low-resolution
clinical imaging data of patients with acute ischemic stroke as they are acquired in the emergency department,
and expand the concept by incorporating longitudinal and spatial lesion information to help improve outcome
modeling. Aim 1 will investigate the concept of effective reserve and its feasibility in patients with acute ischemic
stroke. We leverage two large-scale, retrospective stroke cohorts with clinical imaging available (single site:
N=453, multi-site: N=912). To ensure the translational nature of effective reserve, we will enhance existing and
develop new deep-learning enabled image processing pipelines to extract the required quantitative imaging
biomarkers. These biomarkers will then be used to model functional outcome, measured as modified Rankin
Scale score, ~90 days post-stroke. Aim 2 will develop longitudinal assessment methodologies for effective
reserve and investigate how a drop in effective reserve post-stroke impacts stroke outcome. Aim 3 will further
enhance this principle by harnessing spatial information of the stroke lesion and determining its impact on the
brain’s ability to compensate for pathology. An important and unique feature of this project lies in its direct
translational potential, as it is assessed on stroke neuroimaging data acquired in the emergency department to
answer important questions about the brain’s ability to compensate for the acute vascular event and its focus on
protective mechanisms in the brain relating to brain health. To achieve these goals, this project leverages unique
data and multidisciplinary expertise, to create a clinically available, longitudinal, and spatially specific biomarker
that enhances real-time stroke prognostication, and which can guide individualized patient care to improve
outcomes.

Public health relevance
Project Narrative With aging populations in the US and worldwide and the associated increasing risk of stroke, understanding the determinants of post-stroke outcome leading to functional independence is of great clinical and societal importance. ERIS characterizes the brain’s innate capability to withstand detrimental pathological events, specifically the remaining brain reserve that enables us to compensate for acute, negative effects of stroke. This quantification of the available, effective reserve will at the completion of ERIS become a clinically available and spatially specific biomarker that enhances real-time stroke prognostication, and which can guide individualized patient care to improve outcomes.